Investigating contributions of BRCA2 DNA-binding domains toward maintaining genome integrity

ABSTRACT
Conserved mechanisms exist to eliminate DNA damage, which, if left unrepaired, can cause gene mutations and
genome rearrangements to trigger neoplastic cell transformation and oncogenesis. In particular, homologous
recombination (HR) represents a high-fidelity tool for the repair of DNA double-strand breaks (DSBs), interstrand
crosslinks, and collapsed DNA replication forks. Proper execution of HR requires the tumor suppressor BRCA2
(Breast Cancer 2). Germline mutations in BRCA2 lead to breast and ovarian cancer and also the cancer-prone
syndrome Fanconi anemia. Moreover, somatic driver BRCA2 mutations are found in a variety of cancer types.
Further work is necessary to elucidate the mechanistic role of BRCA2 in HR repair. Importantly, the research
proposed herein will help define the contributions of two distinct DNA binding domains toward the function of
BRCA2 as a “recombination mediator,” specifically in facilitating the assembly of complexes of the RAD51
recombinase on single-stranded DNA derived from the processing of DSBs. Our central hypothesis posits that
the two DNA-binding domains within BRCA2 play an essential role in guiding BRCA2-dependent DSB repair and
replication fork preservation through the engagement of single-stranded DNA and DNA structures present in
processed DSBs. We will conduct a variety of biochemical, genetic, and cell biological studies under two specific
aims to test this central tenet. Throughout these experiments, we will delineate how genetic mutations within
each DNA binding domain affect key aspects of HR and replication fork preservation. The results from this
fellowship project will not only expand our understanding of how the BRCA2 DNA-binding domains contribute to
the maintenance of genome stability, but they will also shed light on how mutations within these domains
ultimately cause malignancy. Furthermore, we expect our findings to help identify new targets and pathway pivot
points for the development of novel cancer therapeutics.

Public health relevance
PROJECT NARRATIVE Genetic mutations in the tumor suppressor BRCA2 engender defects in DNA repair to ultimately cause cancer, and many of these variants still harbor unknown effects on BRCA2 function. Understanding how the DNA-binding domains in BRCA2 contribute to DNA repair would advance our knowledge of how mutations in these domains compromise genomic stability and lead to cancer development. These studies will lay the foundation for future endeavors to devise efficacious cancer treatment regimens.